Dynamic Imaging of Lung Ventilation and Perfusion Using CT and MRI

Dynamic Oxygen-Enhanced MRI of Lung Structure and Function, PI: Sean B. Fain.
Abstract
This project will develop and optimize oxygen-enhanced (OE) imaging of dynamic ventilation of the lungs
simultaneously with high resolution acquisition of lung parenchymal anatomy in a single, free-breathing 7-minute
acquisition using 3D ultra-short time to echo (UTE) MRI. Advances in 3D UTE MRI now support regional imaging
of lung anatomy with CT-like contrast, full chest coverage, and isotropic 1 mm spatial resolution. We will employ
advanced motion compensation reconstruction with manifold-based deep learning and UTE center-out k-space
trajectories to isolate respiratory motion from T1 changes due to oxygen wash-in and wash-out during free-
breathing. The resulting motion compensated reconstruction provides both quantitative ventilation and high-
resolution structure in a single 7-minute series. Multiple chronic lung diseases will be studied with this approach
to establish utility and repeatability of the method in comparison to quantitative chest CT and hyperpolarized
129Xe MRI. Our preliminary data demonstrates the utility of MRI-only exam of lung structure and ventilation in a
manner similar to that provided by nuclear SPECT with technegas and X-ray CT but without ionizing radiation.
We hypothesize that 3D UTE MR imaging of ventilation dynamics will capture co-localized structure-function for
monitoring ventilation heterogeneity relative to structural features of lung disease, including fibrosis, granulomas,
mucus plugging, bronchiectasis, ground glass, and fibrosis. Radiology expert reader studies will be performed
with direct comparison of UTE MRI with quantitative chest CT for depiction of structural and functional (derived
from static multi-volumetric images) abnormalities, and OE MRI regional patterns of ventilation to hyperpolarized
129Xe MRI. We seek to create an MRI method and protocol for structure-function assessment of chronic lung
disease with broad access, no exposure to ionizing radiation (allowing for longitudinal assessment at increased
granularity), and using a safe, inexpensive and widely available paramagnetic gas. The specific aims of the
project are to: 1) Improve data acquisition efficiency for 3D UTE MRI at clinical field strengths; 2) Develop
dynamic OE MRI of oxygen ventilation wash-in and wash-out during free breathing, and 3) Develop OE
MRI visualization and analysis tools for regional structure-function associations. The 3D OE MRI
approach is inexpensive, uses proton-based contrast and can characterize both structural and functional aspects
of chronic lung disease in a manner similar to SPECT/CT without concern for ionizing radiation exposure.

Public health relevance
Advances in Magnetic Resonance Imaging (MRI) now support regional imaging of lung structures with CT-like contrast and high spatial resolution. The versatility of MRI data acquisition includes motion detection that can be used to track changes in lung inflation and oxygen distribution during free-breathing. This project will develop oxygen-enhanced imaging of ventilation of the lungs and high-resolution acquisition of lung anatomy in a single, free-breathing 7-minute acquisition using 3D ultra-short time to echo MRI and study multiple chronic lung diseases to establish utility and reproducibility.